A vaccine design to induce protective B and T cell immunity against hepatitis C virus

ABSTRACT – OVERALL COMPONENT
The overall goal of this U19 project is the development of an HCV vaccine to prevent disease progression after
virus exposure in a vaccinated host. Our overall approach is based on a growing body of data from studies in
patients undergoing primary HCV infections indicating that a subset of these individuals generates immune
responses that result in viral clearance and conferring immunity against reinfection. This naturally occurring
protective immunity appears to include early and robust humoral and cellular responses during the acute phase
of infection. Consequently, the early kinetics, strength, and quality (i.e., cross-protective capacity of both humoral
and cellular responses against the diversity of the evolving HCV quasispecies) are critical for efficient clearance
of repeated exposures to diverse HCV isolates/infections in at-risk individuals. Thus, a successful vaccine will
need to induce robust and durable adaptive B and T cell immune responses in the vaccinated host. This Program
is designed to achieve this goal by four complementary Projects and a Scientific Core. Project 1 focuses on a
structure-guided approach to develop an immunogen that enhances the induction of broadly neutralizing
antibodies (bNAbs) including those when combined lead to synergistic virus neutralization. This project will
interact extensively with Project 4 on structural analysis of HCV envelop glycoproteins and on structural aspects
of bNAbs and receptor binding to HCV particles. Project 2 will design HCV NS Mosaic antigens for T cell
recognition of HCV genotypes and subtypes that cause most infections globally. Mosaic antigens are designed
computationally by recombination of viral genomic sequences retrieved from databases. Project 3 takes a
systems approach to evaluate short- and long-term B and T cell responses and innate responses to vaccination
with vaccines that are formulated in Projects 1 and 3, and in combination with powerful adjuvants. These studies
will be undertaken in non-human primates that will be executed in a Scientific Core. The Administrative Core will
provide the operational support necessary to successfully achieved the goals we have laid out for each project
and program as a whole. Taken together, the work proposed in these projects and scientific core are highly
interdependent that will lead to a vaccine design capable to elicit protective B and T cell immunity against HCV.
We expect that at the end of this program project, we will have a candidate vaccine to begin pre-clinical studies
that will progress to Phase I/II clinical trial.

Public health relevance
NARRATIVE – OVERALL COMPONENT The CDC estimates that 3 million people are living with hepatitis C virus (HCV) infection in the United States and there is an annual infection rate of 34,000 new infections. This pU19 proposal focus on the development of a vaccine that will elicit broadly protective antibodies and cellular responses that are long-lasting. We expect that at the end of this program project, we will have a candidate vaccine to begin pre-clinical studies that will progress to Phase I/II clinical trial.